Preventing Seizures and Associated Memory Loss in Alzheimer's Disease by Blocking Tau Interactions with SH3-containing Proteins.

PROJECT SUMMARY
Up to 60% of patients with Alzheimer’s disease (AD) exhibit seizures and network hyperactivity, leading to a
faster cognitive decline. Therefore, seizures in AD should be an important focus for therapeutic interventions.
The microtubule-associated protein tau, a central factor in AD pathogenesis, mediates seizures and associated
memory loss in models of AD, suggesting that targeting tau could effectively treat seizures in AD. However, there
is a fundamental gap in understanding how tau contributes to seizures in these models. Broadly reducing tau
levels successfully prevents seizures; however, reducing tau also causes deleterious effects in aged mice and
the safety of this approach in the adult human brain is unknown. Therefore, a better understanding of how tau
contributes to seizures is needed in order to develop more precise therapies targeting tau. The overall objective
here is to identify a mechanism by which tau mediates seizures and related functional deficits in mouse models
of AD and genetic epilepsy. The applicant has obtained preliminary data indicating that blocking tau’s interactions
with SRC Homology 3 (SH3)-containing proteins can prevent seizures and associated memory loss in AD. The
central hypothesis, based on the applicant’s preliminary data, is that tau binds to SH3-containing enzymes on its
proline-rich region, and regulates network activity by modulating the activity or cellular localization of these
enzymes. Previous studies, supportive of this concept, have indicated that binding between tau and the tyrosine
kinase Fyn, which regulates excitatory receptors, are involved in tau’s ability to regulate seizures. The applicant’s
preliminary data expands on these findings to indicate additional SH3-containing enzymes that bind tau and are
involved in this phenomenon. The rationale for the proposed research is that, once it is known which enzymes
are important for tau’s ability to mediate seizures, tau’s binding affinity with these enzymes can be manipulated
pharmacologically, resulting in new and innovative approaches to the prevention and treatment of seizures and
associated memory loss in AD. Guided by strong preliminary data in which the applicant created two novel
mutant tau knockin mouse models, this hypothesis will be tested by pursuing two specific aims: 1) Determine
the influence of variants in the proline-rich region of tau that prevent its binding to SH3-containing enzymes on
signal transduction initiated by Aβ oligomers, which are epileptogenic peptides linked to AD, and excitotoxins,
and 2) Determine the extent to which these variants in tau prevent seizures, behavioral deficits, and premature
mortality in mouse models of AD and genetic epilepsy. The proposed research is innovative because it
represents a substantive departure from the status quo by shifting focus to tau’s upstream modulation of cell
signaling related to Aβ and excitotoxicity. This contribution is expected to be significant because it will have broad
translational importance in the prevention and treatment of seizures and associated memory loss in AD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of mechanisms underlying epilepsy in Alzheimer’s disease is expected to provide new targets for preventive and therapeutic interventions. Thus, the study is relevant to the NIH’s mission to develop fundamental knowledge that will help to reduce the burden of neurodegenerative disease.